Evaluating the Association Between General Chronic Pain Liability and Clinically Recognized Substance Use

Project Summary/Abstract
Chronic pain presence is overrepresented among individuals with substance use disorder (SUD), with
evidence suggesting that in the United States, over two-thirds of individuals with a drug use disorder have
chronic pain. To inform efforts to meliorate the burden of co-occurring chronic pain and substance use, it is
critical to first clarify their underlying mechanisms. Studies often conclude that chronic pain may be causally
linked to substance use. Yet, the lack of research accounting for the heterogeneity across and comorbidity
among chronic pain conditions themselves, as well as plausible alternative explanations of chronic pain and
substance use comorbidity related to shared familial factors (i.e., genetic and environmental confounding) pose
a challenge for such conclusions. The overall objective of the proposed project is to estimate the effect of
chronic pain on substance use accounting for the heterogeneity across and comorbidity among chronic pain
conditions. An additional objective involves receiving training that will help foster an independent research
career assessing substance use and its comorbidities. The rationale for the project is that deepening
understandings of chronic pain’s effect on risk of SUD/OD is likely to further knowledge of chronic pain and
substance use comorbidity, which is critical for informing research and substance use prevention and
treatment initiatives for individuals with chronic pain. The central hypothesis is that a general chronic pain
liability can help explain risk of SUD/OD, which could promote nuanced pain management among individuals
concurrently using substances. The proposal will test this hypothesis in two specific aims: 1) Estimate general
and condition-specific associations between chronic pain conditions and SUD/OD and 2) Estimate general and
condition-specific effects with SUD/OD accounting for familial confounding by design. Aim 1 will implement a
bifactor model capturing chronic pain condition comorbidity and heterogeneity to assess the association
between general chronic pain liability and risk of SUD/OD. Aim 1 will also compare this model to alternative
models to justify considering the role of general chronic pain liability in risk of SUD/OD. Aim 2 will apply a co-
twin control design, comparing twins discordant on chronic pain and SUD/OD to adjust for unmeasured
confounding by factors shared by siblings. The proposed research is innovative, in the applicant's opinion,
because it capitalizes on a unique, prospective, population-based twin cohort to assess the relationship
between condition-general and condition-specific chronic pain processes and SUD/OD. Further, the proposal
will use a co-twin control approach to account for shared familial factors more effectively than prior research.
This proposal is significant because it is expected to help clarify the extent to which chronic pain affects risk of
SUD/OD, which will help ascertain if reducing chronic pain decreases risk of SUD/OD or if intervening on other
factors is more effective for reducing risk of SUD/OD among individuals with chronic pain.

Public health relevance
Narrative Clarifying the underlying processes contributing to chronic pain and substance use comorbidity has the potential to inform substance use prevention and treatment initiatives for individuals with chronic pain. Evidence of associations between chronic pain and substance use consistent with a causal hypothesis would suggest that addressing chronic pain is critical for reducing risk of substance use. Alternatively, evidence inconsistent with a causal role of pain would suggest that intervening on other underlying factors may be more effective.